Site-Selective C-H Borylation Directed by Noncovalent Interactions

PROJECT SUMMMARY
Almost all new drugs on the market emerged from the synthesis of thousands of structurally similar molecules.
Once a compound is identified to possess targeted therapeutic activity, medicinal chemists generate an
extensive array of derivative compounds with numerous modifications in structure to tune key properties, such
as potency, selectivity, stability and solubility. The ability to structurally edit a single compound at multiple sites
would circumvent the need for lengthy de novo syntheses of each derivative, exponentially improving the
efficiency of the drug discovery process. Transition metal-catalyzed functionalization of C–H bonds has emerged
as a powerful tool for late-stage derivatization of complex molecules. However, selectivity between multiple C–
H bonds in similar structural environments remains a challenge. Current methods to control site selectivity suffer
from various shortcomings, including the need to install and remove directing groups, limitation to simple
structures, and inability to overcome large differences in the reactivity of C–H bonds. The proposed research
focuses on the development of a systematic and tunable strategy to control site selectivity of iridium-catalyzed
C–H borylation that is capable of overcoming inherent substrate preferences and that can target specific C–H
bonds. The proposed approach leverages a variety of common functionalities in bioactive molecules as
recognition sites, conferring generalizability while avoiding the need for directing groups. In addition, the
proposed approach is informed by a recent breakthrough by the sponsor’s laboratory showing a dramatic
activating effect of 2-aminophenanthroline ligands on the borylation of C–H bonds. The impact of this research
is a flexible tool for precise structural editing of bioactive compounds. Specifically, the proposed research will
include the synthesis of a suite of ligands derived from 2-aminophenanthroline, bearing interaction sites that are
connected to the backbone with a sidearm linker and that are capable of attractive noncovalent interactions with
common Lewis-basic functionalities. A modular synthetic approach is described, enabling the assessment of
various interaction sites as well as structure and connectivity of the sidearm linker. Iridium catalysts generated
from the ligands will be tested for their ability to overcome the inherent selectivity of substrates toward undirected
borylation. Upon success, a series of sites will be targeted for functionalization by adjustment of the linker
structure. Subsequent functionalization of complex, biologically active compounds will demonstrate generality of
the method and applicability to lead optimization. Mechanistic studies will be integrated in each step of the
proposed research to guide catalyst design and improve reaction efficiency and site-selectivity. Achieving the
specific aims of the proposed research will provide chemists with a powerful strategy for precise, targeted, late-
stage diversification of complex organic molecules, thereby accelerating the generation of biologically active
compounds.

Public health relevance
PROJECT NARRATIVE Development of new small molecule drugs is expedited by the ability to rapidly generate libraries of organic compounds for evaluation of drug-like properties. This proposal describes a method to selectively edit carbon-hydrogen bonds within compounds that have the potential for treating human diseases, enabling facile access to structural derivatives and streamlining optimization of drug efficacy. Utilizing a suite of novel catalysts designed to maximize reactivity while also controlling selectivity, this method leverages the properties of functionalities ubiquitous to bioactive molecules to target specific carbon-hydrogen bonds for conversion into carbon-boron bonds, a versatile precursor for numerous functional groups.